Critical protein interactions for piRNA biogenesis

PROJECT SUMMARY
P-element induced wimpy testis (PIWI)-interacting RNAs (piRNAs) are ~24-34 nt non-coding RNAs that have
been discovered in diverse species. Repressing the expression of transposable elements via piRNAs represents
a critical defense mechanism for germ cells to maintain genomic integrity. The piRNA biogenesis largely occurs
at nuage, the amorphous electron-dense granules with no limiting membrane in the cytoplasm. One specific type
of nuage, intermitochondrial cement (IMC), is identified with uniquely clustered mitochondria and
ribonucleoproteins as “cementing material” in embryonic germ cells, postnatal spermatogonia, and early-stage
spermatocytes. RNA-binding proteins such as PIWI family members are critical for piRNA biogenesis at IMC.
Disrupting IMC formation or removing RNA-binding proteins from IMC often blocks spermatogenesis and impairs
male fertility. Notably, none of the PIWI proteins possesses mitochondrial localization signal (MLS), and thus
they must rely on other proteins to be recruited to mitochondria or to functionally communicate with IMC. However,
it remains a knowledge gap in how mitochondria recruit PIWI proteins to form IMC for piRNA biogenesis. To fill
in this gap, in this R03 project, we will reveal how ASZ1, a mitochondrion-localized germ cell-specific protein,
recruits PIWI proteins to IMC for piRNA biogenesis (Aim 1) and subsequently impacts male germ cell
development (Aim 2). Impact: Germ cells are essential carriers to pass genomic information across generations.
This process requires properly generated piRNAs to maintain germline DNA integrity. By unveiling essential
protein interactions at IMC and defining their roles in IMC construction, piRNA biogenesis, and germ cell
development, this project will generate novel knowledge about how the piRNA processing machinery is
assembled to maintain genomic integrity, and thus critically inform the mechanistic causes of male infertility
related to piRNA biogenesis for targeted therapies. Findings from this project may also lead to a novel strategy
for developing non-hormonal male contraceptives.

Public health relevance
PROJECT NARRATIVE Germ cell development requires properly generated piRNAs to maintain germline DNA integrity, the failure of which will impair male fertility. This project aims to unveil how the piRNA processing machinery is constructed in male germ cells, thus critically informing the mechanistic causes of male infertility for targeted therapies. Findings may also lead to a novel strategy for developing non-hormonal male contraceptives.